The RCMI Program in Health Disparities Research at Meharry Medical College

Abstract: In the application of our currently funded RCMI center, we proposed to address health disparities at multiples scales of research: from micro to macro environments. With institutional collaboration and support, our application proposed to continue the long-term RCMI support of enabling high quality basic, behavioral, and clinical research to eliminate health disparities as our long-term goal. The RHDR@MMC is not discipline or disease focused, but emphasizes the disruption of disparity at all scales, from proteins to the human ecosystems of the populations we serve. Our re-envisioned Research Infrastructure Core will provide expert technical support in areas relevant to the research projects, as well as services such as design, biostatistics, bio and health informatics, and cross-training support to benefit ALL researchers at the institution. We have assembled a cadre of scientists including basic, behavioral, dental clinicians, population-based, and community-engaged researchers at Meharry to participate in this endeavor. Our aims are to: 1. Support four outstanding research projects addressing HIV/AIDS, prostate cancer, racial and ethnic differences in periodontal disease microbiomes, and adversity-driven chronic pain to advance fundamental understanding of these health disparities. 2) Strengthen core technologies and expand bioinformatics and biostatistical services supporting the four research projects, as well as all Meharry research faculty, to increase institutional success in extramural funding studying diseases that disproportionally affect minority and other health disparity populations. 3) Nurture an environment conducive to developing new and early career investigators by facilitating a mentorship network, enhancing professional developmental activities, and providing pilot project funds. 4) Improve and expand relationships with community-based organizations that partner with Meharry. 5) Recruit outstanding magnet scientists to energize current faculty and contribute to our research capacity in cancers of the underserved, infectious diseases including HIV-AIDS, disparity-causing differences in microbiomes of minorities, and societal adversity leading to debilitating chronic pain in African Americans. We designed our RCMI Program in Health Disparities Research to address health disparities through research in diseases that affect the community it serves, engagement of this community in its solutions, and creating technologies and research infrastructure to serve the institutional scientific community and its academic and community partners. This collaborative approach is critical because finding the right answers to address disparities in health equity involves all of us. Prostate cancer research is one of our RCMI Center’s major research focuses.

Public health relevance
Project Narrative The goal of this project is to understand whether or not high expression of a receptor protein known as Toll like receptor-4 (TLR4) can distinguish an aggressive form of prostate cancer in men, particularly African American men.